Role of synaptotagmins and neurexin ligands in homeostatic synaptic plasticity

Center PI: Malenka, Robert, Principal Investigator: Chen, Lu/Südhof, Thomas (Project 3) Summary A long-standing question in the field of neuroscience is how plastic changes at synapses in a circuit enable learning, encode memory, and drive behavior. Compared to the progress made in relating Hebbian plasticity to animal learning, little is known about the behavioral significance of homeostatic synaptic plasticity. Based on the newly discovered signaling pathway involved in homeostatic synaptic plasticity ? the synaptic retinoic acid pathway, and building on the progress made in the past years, this study aims to deepen our understanding of homeostatic synaptic plasticity by further exploring the involvement of postsynaptic exocytosis machineries and trans-synaptic adhesion molecules in homeostatic synaptic plasticity. Moreover, taking advantage of the known molecular components uniquely involved in the homeostatic synaptic plasticity, the study will probe in vivo functional significance of homeostatic plasticity by applying state-of-art genetic tools in animal behavioral studies. Through close collaboration with other projects of the Center, this project hopes to provide conceptual advancement to our understanding of homeostatic synaptic plasticity and retinoic acid signaling. Relevance The candidate molecules investigated in this project have been implicated in Autism spectrum disorders. Dissecting their involvement in homeostatic synaptic plasticity and RA signaling and examining the functional impact on animal learning when homeostatic plasticity is compromised will further our understanding of circuit maladaptation underpinning mental illnesses. PHS 398/2590 (Rev. 11/07) Page 1 Summary

Public health relevance
Center PI: Malenka, Robert, Principal Investigator: Chen, Lu/Südhof, Thomas (Project 3) Project Narrative This application proposes to use state-of-art genetic tools to explore the molecular basis as well as the in vivo function of retinoic acid-mediated homeostatic plasticity. In charactering the involvement of synaptic proteins that have been implicated in various neurological disorders in the context of homeostatic synaptic plasticity, and the contribution of homeostatic synaptic plasticity to the overall learning capacity of the organism, this application will contribute to a better understanding of the synaptic and circuit underpinning of mental illness, and thus address the goals of PAR-14-120. PHS 398/2590 (Rev. 11/07) Page 1 Project Narrative